NARCH XIII- Student Development

Program Summary-Overall
Indian Health Council, Inc. (IHC) with California State University San Marcos, Palomar Community
College, San Diego State University (SDSU) and University of California San Diego (UCSD), intends to
build upon their already existing long-term research partnership in the proposed projects/studies in the
NARCH XIII application.
The aims of the CA-NARCH SDP include: 1) To engage high school students interested in American
Indian/Alaska Native Health to increase their knowledge and their families knowledge of STEM, STEM
degrees, and STEM career to increase matriculation into these areas; 2) Identify and recruit AI/AN
students and students interested in AI/AN health in the biomedical and behavioral sciences from
community college through graduate school into the CA-NARCH SDP program; 3) Retain AI/AN
students and students interested in AI/AN health in their respective higher education programs and
develop and enhance their knowledge, skills, science-self efficacy, and persistence to succeed in STEM
programs to successfully matriculate into graduate programs; 4) Engage and provide training for AI/AN
students and students interested in AI/AN health in biomedical and health research to increase their
competitiveness for jobs/graduate school and their likelihood of becoming health/science researchers; 5)
Increase the cultural interface and competencies of the CA-NARCH students and encourage AI/AN
community engagement and trust in research. Centered at IHC, the CA-NARCH SDP has established
infrastructure with a SDP team, including a full-time native coordinator (Luiseño), and an established
presence and leads on the 4 surrounding campuses. Students are recruited from the 4 campuses, AI/AN
organizations, local communities, All Tribes American Indian Charter School, and other organizations.
Retention methods are multiple and include engaging students in research through the existing NIH and
NSF funded programs. The CA-NARCH Directed Research (CANDR) program with campus and
community based research is a summer and/or a yearlong research program. Students will receive
continual mentorship from the CA NARCH SDP team, a peer mentor program that supports high school
students. Students will work with their mentor to create individual development plans and will receive
socio-cultural support.
Lastly, the Administrative Core will function as administrative support for the student project and
individual research studies by providing ethical research training, providing/dispersing information on
resources and mentoring opportunities, and guidance in evaluation planning.

Public health relevance
Program Narrative Indian Health Council, Inc. (IHC) with California State University San Marcos, Palomar Community College, San Diego State University (SDSU) and University of California San Diego (UCSD), intends to build upon already existing long-term research partnerships with the following proposed projects/studies in the NARCH XIII application: Student Development Program (SDP) and the Administrative Core. These projects will further expand and refine strategies to recruit students from local academic institutions into biomedical and behavioral sciences as well as, continue to provide strong mentorship and guidance for the students in and outside of the region and by providing administrative and fiscal oversight, coordinating communication and dissemination of information to foster the academic and community partnerships, supporting the CA-NARCH SDP in establishing a trained cohort of scientists dedicated to impacting the health disparities of AI/AN populations, and by guidance in and conducting relevant evaluation to ensure the success of the Core and CA-NARCH SDP.